IMMUNIZATION OF MACAQUES WITH SINGLE-CYCLE SIV AS NOVEL AIDS VACCINE APPROACH

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Immunization with Envelope-Modified Strains of Single-Cycle SIV Reduces Viral Loads After Repeated Low-Dose Challenge with SIVmac251.